Development of dual effective kinase inhibitors as syndromic treatment of Giardiasis and Cryptosporidiosis

Project Summary/Abstract
The potential for devastating consequences of cryptosporidiosis or giardiasis diarrhea in immunocompromised
patients and malnourished children emphasizes the need for a single effective therapy that could be used
syndromically where diagnosis may be delayed or uncertain. This will also be applicable for asymptomatic
presentations of both diseases. The etiologic parasites colonize and reproduce in the small intestines of
mammalian hosts where they are associated with epithelial cells microvilli. Hence, potential for finding dual
therapeutic is high based on common anatomical site of infection. Protein kinase inhibitors have attracted
considerable attention as potential therapeutics since a number of them have been released as drugs in recent
years and many are in various phases of clinical trials. In a semi-High throughput screening of MMV Pathogen
box and Celgene Global Health programs library, we identified dual hitting kinase inhibitors from 2 chemical
scaffolds. The scaffolds offer new medicinal chemistry opportunities for development of effective multi-parasite
therapeutics against cryptosporidiosis and giardiasis. This research proposal capitalizes on these preliminary
findings to hypothesize that effective single agent therapy that could be used syndromically for treatment of either
cryptosporidiosis or giardiasis is possible. Analogues of the 2 scaffolds already in hand and newly synthesized
in Aims 1a will be screened in Aims 2a to determine in vitro efficacy in blocking parasites growth using direct
phenotypic screening to develop structural activity relationship. We will also be collecting other standard in vitro
ADMET and physicochemical parameters such as solubility, stability in simulated gastric/intestinal fluids, and
mouse/human microsome stabilities, in-house hERG assay etc as Go/NoGo filters. Criteria for moving forward
to in vivo studies will include dual parasites killing efficiency, selectivity, static vs. cidal, stability in both gastric
fluids and gut Phase 1 metabolism, and ease of medicinal chemistry development. Since necessary factors for
clinical relevance have not been established in these scaffolds, we will use early leads from Aims 2b to define
the PK/PD properties necessary for optimum animal in vivo efficacy in Aim 2b. We will perform further in vitro
safety profiling for early leads focused on further improving selectivity including quantitative proteomic analysis
of offtarget safety kinases, cytochrome P450 isoenzyme activities and metabolite identification in Aims 1c. Using
medicinal chemistry based iterative reasoning to synthesize analogs, we will do lead optimization for efficacy,
selectivity, PK/ADMET properties, in vivo efficacy and resistance under Aim 1b. In Aim 3; optimized leads will
be evaluated for clinical usefulness with experiments to define any liabilities related to CYP activities, mammalian
kinome profile, AMES test, micronucleus assay and a safety panel of human receptors and ion channels. Other
experiments will include final toxicology studies, additional resistance studies and metronidazole combination
studies. The product of this research study would be useful as parasitic diarrheal therapeutic with the potential
for broad spectrum activity. It will have significant public health benefits in many developing regions of the world.

Public health relevance
Project Narrative The ultimate goal is to discover kinase inhibitors that could be developed as an oral multi parasite effective therapeutic against cryptosporidiosis and giardiasis diarrhea with potential usefulness in other intestinal parasitic diseases. We have demonstrated that kinase inhibitors from two chemotypes have selective inhibition of the parasites with one shown to be therapeutically effective in mouse infection models of Giardia lamblia and Cryptosporidium parvum. The common anatomical infection site of these etiological agents and symptomatic presentations should aid in finding a dual use drug because of similar pharmacokinetic (PK) and pharmacodynamic (PD) requirements for a syndromic treatment of the diseases.